Characterization of Selenomonas sputigena pathogenesis

Project Summary
Selenomonas sputigena is a Gram-negative, flagellated, motile periodontal bacteria highly associated with
periodontitis. S. sputigena is more prevalent and abundant in periodontitis gingival sites than in healthy gingiva.
Selenomonas spp. are routinely isolated from periodontal samples, and gingival inflammation has long been
associated with an increased abundance. Characterization of the human oral microbiome has highlighted that
many bacteria, including S. sputigena, are associated with periodontitis. However, very little is known about the
pathogenic capabilities of the organism. To that end, we recently initiated the first comprehensive study of S.
sputigena pathogenesis and virulence properties. We demonstrated S. sputigena binds to gingival epithelial cells
and promotes extensive pro-inflammatory cytokine secretion. Interestingly, we observed that S. sputigena
evaded TLR5 activation, which recognizes flagellin. This is clinically important as our preliminary data
demonstrate that motility and chemotaxis genes are highly expressed during periodontitis. Additionally, S.
sputigena is densely packed within plaque biofilm, contributing to its structural organization, and interacts with
other periodontal bacteria in polymicrobial communities. Finally, S. sputigena produces the secondary
messenger c-di-GMP, which regulates motility and biofilm development. Our scientific premise is that motility
and biofilm development are virulence factors that contribute to periodontal disease. Based on our preliminary
data and the literature, we hypothesize that S. sputigena c-di-GMP regulates lifestyle decisions between motility
and biofilm formation, impacting inflammation and pathogenicity. The aims of this study will test our hypothesis
in two approaches: 1) we will determine c-di-GMP levels in biofilms, and during planktonic growth, while
identifying the proteins that bind c-di-GMP and carry out effector functions and, 2) we will characterize the
immune mediators, leukocyte infiltration and alveolar bone loss caused by S. sputigena in murine models of
infection. Successful completion of this study will advance our understanding of a long-recognized but poorly
understood periodontal pathogen. Current therapeutic strategies for periodontitis were developed based on a
few well-characterized pathogenic bacteria. The involvement of under-studied bacteria, such as S. sputigena, in
the initiation and progression of periodontitis, may lead to re-evaluating treatment approaches or uncovering
novel strategies to prevent or treat periodontitis.

Public health relevance
Project Narrative Periodontitis is one of the most common diseases of humans and is caused an increase in bacterial accumulation and a shift in the microbial species present that cause severe inflammation. The goal of this study is to examine the c-di-GMP signaling system utilized by the understudied periodontal pathogen, Selenomonas sputigena, that promotes inflammation and bone loss. Understanding the mechanisms that drive bacterially induced periodontal inflammation is critical to development of novel therapeutics or approaches to prevent periodontitis.